Angiotensins, Prostaglandins-Adrenergic Interactions

DESCRIPTION (provided by applicant): This proposal is an extension of the previous work and is aimed to test the hypothesis that Group IV cytosolic phospholipase A2 (cPLA2α)plays a critical role in the pathogenesis of hypertension and hypertension- associated target-organ damage. This novel hypothesis is based on intriguing preliminary data that cPLA2α gene disruption in mice (cPLA2α-/-) ameliorates both Ang II- and DOCA-salt-induced hypertension. Moreover, cPLA2α gene disruption prevents Ang II-induced target-organ damage (as evidence by reductions in cardiovascular dysfunction, cardiac and renal fibrosis in cPLA2α-/- mice). cPLA2α gene disruption also ameliorates Ang II-induced renal infiltration of macrophages and T lymphocytes, suggesting alterations in hypertension-induced immune system activation. More imporantly, cPLA2α gene disruption prevents production of reactive oxygen species (ROS) in subfornical organ (SFO) in the central nervous system associated with Ang II-induced hypertension, effects that are reversed by expression of adenovirus (Ad) cPLA2α DNA in the SFO of cPLA2α-/- mice. To investigate the innovative concept that cPLA2α is involved in the pathogenesis of hypertension and end organ damage, the following specific aims will be addressed. Aim 1. To determine the contribution of cPLA2α to Ang II- and DOCA-salt-induced hypertension. Aim 2. To determine the contribution of cPLA2α to Ang II- and DOCA-salt-induced target-organ damage. Aim 3. To determine the contribution of cPLA2α to Ang II- and DOCA-salt-induced immune system activation. Aim 4. To determine the role of cPLA2α to Ang II and DOCA-salt-induced changes in the central nervous system. To accomplish the objective of these aims, the state-of-the-art in vivo and in vitro cellular and molecular biology and histologicl and immunohistochemical techniques will be used. These include: a) 1) cPLA2α+/+ and cPLA2α- /- mice; 2) Adenovirus (Ad) cPLA2α shRNA and Ad cPLA2α DNA; 3) telemetry for measuring BP and echocardiography for assessing cardiac function; 4) histological, immunohistochemical, and fluorescence microscopy and biochemical techniques; 5) flow cytometry to determine immune cell population in the blood and tissues; 6) T cells from the spleen of transgenic mice to determine the mechanism of cPLA2α-induced NADPH oxidase activity and ROS production; and 7) HPLC-LC-ESI-MS to measure eicosanoids and other possible AA metabolites. The proposed studies will provide novel insights into the mechanism linking cPLA2α to activation of NADPH oxidase and the immune system in the development of hypertension and its pathogenesis. Moreover, these studies should allow to demonstrate that cPLA2α is a potential target for developing novel, selective, water-soluble inhibitors of this enzyme for treating hypertension and associated target-organ damage and for stimulating further basic and clinical research to determine possible polymorphisms in the cPLA2α gene in hypertension and cardiovascular and renal diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed studies will provide an insight into the mechanism linking cytosolic phospholipase A2� (cPLA2�), an enzyme that promotes release of the fatty acid arachidonic acid, to activation of NADPH oxidase, an enzyme that generates reactive oxygen species, and the immune system in the development and pathogenesis of high blood pressure. Moreover, our studies will demonstrate cPLA2� as a potential target for the development of novel agents for treating high blood pressure and associated cardiovascular-renal dysfunction and end organ damage.